GENETIC STUDY OF ANIMAL VIRUSES

We will continue our studies aimed at construction of mammalian cells with nonsense suppressors. We will construct, by in vitro methods, mutations in the anticodon region of cloned serine-tRNA genes from human DNA. These in vitro-made suppressor genes will be co-transformed into mammalian cells and tested for function with our previously characterized set of nonsense mutants in the TK gene of herpes simplex virus.